New Jersey Occupational Health Surveillance

Project Summary/Abstract
The New Jersey Department of Health (NJDOH), Occupational Health Surveillance (OHS) Unit
proposes to conduct population-based surveillance of established occupational health
indicators (OHIs) in order to estimate and characterize the burden of specific work-related
injuries and illnesses and compare rates to national estimates and evaluate trends over time.
We propose to enhance and evaluate our surveillance system to expand data collection,
prevention, and intervention activities in NJ. OHS will continue to conduct surveillance of adult
blood lead, arsenic, mercury and cadmium. NJ has regulatory authority to collect occupational
health surveillance data for all occupational diseases and injuries. The specific Aims of the
project are as follows:
1. Maintain and analyze data collected for 23 specified occupational health indicators (OHI)
and conduct an education and outreach effort focused on reducing exposure to asbestos.
2. Analyze specified OHIs to characterize occupational health injuries and illnesses among
vulnerable populations to formulate strategies for interventions. This includes a specific
project focused on youth injuries and a general focus on vulnerable worker populations,
such essential critical infrastructure workers.
3. Maintain data collection of adult blood lead and other heavy metals. Conduct surveillance
of exposed individuals to identify at-risk workplaces for further targeted interventions, such
as education and outreach and referral to regulatory authorities.
The NJDOH OHS Unit proposes two Fundamental Plus projects to enhance our
occupational health surveillance by utilizing and evaluating new data sources and
translating real-time data to public health action. OHS will also develop a framework for
occupational health surveillance of emergent infectious diseases by including workplace
variables in non-traditional datasets, which aims to improve surveillance and mitigate
workplace transmission of COVID-19 in the current pandemic. OHS Unit Staff will conduct
trainings for the collection of industry and occupation information in these nontraditional
surveillance systems, including communicable diseases, contact tracing, and poison
control inquiries. The specific Aims of the Fundamental Plus projects are the following:
1. Promote inclusion and analysis of occupation and industry variables in nontraditional
data sources, through existing and new partnerships to enhance surveillance of
emergent diseases and hazards.
2. Enhance the EpiCenter syndromic surveillance system as a real-time surveillance
system for work-related nonfatal injuries and poisonings.
Establishing and evaluating key findings from these new data sources will position the NJ
state-based surveillance project to strengthen our capacity to conduct surveillance and
build partnerships to protect worker health and safety. This project will cultivate existing
relationships with Rutgers University, our regional NIOSH Education and Research Center,
the NJ Poison Control Center, and other key partners within NJDOH, including the Public
Employee Occupational Safety and Health program and the Communicable Disease
Service. Continued collaboration with current partners, as well as potential new partners
and stakeholders, will improve our future response efforts to work-related injuries and
poisonings in the State.

Public health relevance
Project Narrative New Jersey Department of Health (NJDOH) Fundamental Plus and Adult Blood Lead Occupational Health Surveillance Project Since 1985, the New Jersey Department of Health has conducted surveillance, funded by the National Institute for Occupational Safety and Health (NIOSH), for occupational illnesses and injuries which are reportable under New Jersey regulations that provides the Department with the authority to collect occupational health surveillance data. This proposal details our plans to i) expand on current traditional occupational data collection methods; ii) enhance unique state surveillance systems not traditionally used for occupational health and incorporate the collection of workplace information and iii) develop a framework for future emergent infectious diseases. This improvement of occupational health surveillance will allow for better targeted intervention of at-risk working populations and development of education and outreach materials.